From humans and eukaryotes to viruses and pathogens; how transition metals shape catalysis and allostery

Project Summary
Metalloproteins play a crucial but poorly understood role in how viruses manipulate their hosts and how
key cellular processes are regulated in eukaryotes, parasites, and viruses. Our proposed research program for
the next five years aims to bridge the existing knowledge gap about how metal ions affect the function of enzymes
that are at the nexus of host-pathogen interface, immune response, and dNTP homeostasis. Our strategy is a
conceptualization of our ideas about how metal ions tune activity and regulation of two important enzyme super-
families: viral proteases and SAMHD1 dNTPases.
Viral proteases. Viral polyprotein complexes enclose proteases that not only release the non-structural
proteins required for replication of the viral genome but also harbor moonlighting activities that intercept host
protein function, ultimately derailing immune defense. A number of viral proteases coordinate an essential for
function metallocofactor in a putative Zinc-finger motif that is located far from the proteolytic active site. We
propose that this metallocofactor is an Fe-S cluster and that this center is a common but unrecognized element
in viral proteases. We aim to dissect the metal-dependent activities of four proteases from viruses for which
efficient treatments are lacking: the PLpro from Sars-Cov(2), the Nsp1α from the Porcine Reproductive and
Respiratory Syndrome Virus, the putative cysteine protease (PCP) from the Hepatitis E Virus, and the 2Apro from
Enterovirus 71 (hand-foot-mouth disease). Based on our results that these proteases interchangeably coordinate
[4Fe-4S] clusters or Zn2+, we propose a revision of the well-accepted paradigm of Zn utilization in this class of
enzymes. Our studies promise to resolve the apparent Fe-S cluster/Zn dilemma in viral proteases by
establishing: i) the in vivo physiological cofactor and ii) the biological relevance of this metal binding promiscuity.
SAMHD1 dNTPases. Sterile Alpha Motif and HD-domain containing protein 1 (SAMHD1) is the only
hydrolase in humans that catalyzes the breakdown of cellular deoxynucleotides (dNTPs). SAMHD1 also occurs
in phylogenetically diverse organisms, such as viruses, plants, and human pathogens. This proposal exposes
significant conceptual and methodological gaps about how SAMHD1 dNTPases have evolved to regulate dNTP
levels essential for organism fitness. In this respect our studies promise to delineate, for the first time, molecular
and chemical details that govern SAMHD1 catalysis in the human enzyme as well as the untapped pool of
eukaryotic and viral orthologs. In this proposal we will: i) establish the role of Fe and Mn in activation and catalysis
of human SAMHD1, ii) map the functional repertoire of newly identified SAMHD1 orthologs, and iii) shed light
into the evolutionary and functional diversification of SAMHD1 dNTPases. The projected outcome will broadly
provide a molecular paradigm for dNTP regulation in plants, fungi and parasites that remains entirely unexplored.

Public health relevance
Project Narrative Metal ions serve myriad roles ranging from structure stabilization and multimer formation to catalysis and allostery. As such, they are fundamental elements in pathogenesis, host-virus interactions, as well as regulation of key cellular processes across all domains of life. Our work aims to uncover how cofactor choice dictates structure and function in viral proteases and phylogenetically diverse dNTPases so as to provide the missing molecular-level details required to understand their cellular function and evolution.